Cardiopulmonary Effects of Endotoxin in Normal Human Volunteers

The administration of intravenous endotoxin to healthy human subjects replicates many of the features of clinical sepsis, including fever, leukocytosis, release of inflammatory mediators, a hyperdynamic cardiovascular state, and reversible depression of left ventricular function. Administration of endotoxin endobronchially offers a way to study the early effects of acute inflammation on the lung. - Human Subjects